Juvenile Myositis Pathogenesis and Translational Medicine

Juvenile dermatomyositis (JDM) is a rare complex systemic vasculopathy with prominent involvement of muscle and skin with inflammation involving adaptive and innate immunity. JDM generally causes weakness and disability with significant morbidity sometimes involving organs which can be life-threatening. Myositis-specific autoantibody (MSA) groups define clinical subgroups within JDM. Most patients have a chronic or polycyclic disease course often requiring multiple empiric potent immunosuppressive medications long-term. Although risk factors have been identified, the pathogenesis of JDM is still not fully understood. We co-authored one clinical review of JDM including features, outcomes, treatment and pathogenesis (Rheum Dis Clinics North Am, 2021). Our goal is to further study pathogenic mechanisms and evaluate novel treatments.
An interferon (IFN) signature has been reported in JDM patients with active disease, but the exact role of IFN in disease pathogenesis remains unclear. Given that baricitinib, a janus kinase or JAK inhibitor that can block type I and II IFN signaling, was clinically efficacious in CANDLE and SAVI, we assessed baricitinib in a cohort of refractory JDM as part of a compassionate use program (NCT01724580) and found significant improvement in multiple validated disease activity measures by 24 weeks or 6 months, though improvement was noted as early as 4 weeks. This included improvement in skin disease and weakness as well as improvement in muscle edema or inflammation on MRI. As a proof-of-concept, we showed that IFN signaling gene and protein expression was decreased. There were no serious adverse events and none of the subjects had to hold or discontinue baricitinib. This importantly identifies JAK inhibition with blockade of IFN-signaling as an exciting promising therapy in juvenile dermatomyositis (Ann Rheum Dis, 2021). We evaluated some key validated clinical disease measures after 72 weeks or 18 months of treatment and found continued improvement including patient-reported outcomes. This was presented at the Annual American College of Rheumatology Meeting in 2020 and 2021. Current studies are evaluating gene and protein expression in JDM patients and cell-type specific differences in response to baricitinib. We also are planning a controlled study to better evaluate targeted therapies in juvenile myositis based on pathogenic mechanisms to improve treatment and lessen side-effects in JDM, including a placebo-controlled double-blind study to better assess safety and efficacy of baricitinib in JDM. We also co-wrote an overall look at current and evolving protein kinases including janus kinase inhibitors (Nat Rev Immunol, 2023).
To better understand the treatment response and the mechanisms of disease, we also looked at what markers are related to change in a pilot study of abatacept in refractory juvenile dermatomyositis patients 9 of 10 patients improved based on validated clinical measures. Specifically, we measured multiple inflammatory and interferon-related protein markers and an interferon-related gene score and generally found them to be decreased (Arthritis Rheumatology 2023).
Regarding patient management, we assessed other ways to assess change in patient disease activity and patient treatments. We evaluated how treatments were escalated in the Childhood Arthritis and Rheumatology Research Alliance in refractory JDM patients (Pediatr Rheumatol Online, 2023). We have also looked at performance of clinical assessment of myositis response by validated measures (Rheumatology, 2023).
We are continuing to evaluate peripheral blood protein and gene expression in JDM and myositis-specific autoantibody groups to further evaluate for activity-related biomarkers and identify other dysregulated biologic pathways, which may or may not be related to the IFN dysregulation.